ALZHEIMERS RESEARCH PROJECT - Predicting Chromatin Signatures of Alzheimers Disease and Related Dementia from Peripheral Blood

In the past year, we have completed PBMC immunophenotyping, single cell multi-ome (RNA +ATAC), single-cell RNA, T-cell receptor (TCR) and B-cell receptor (BCR) library generation for the longitudinal cohort. This comprises data from 190 donors (31 cases + 64 controls, two visits each), and a total of 860 sequencing libraries. Sequencing and analysis are actively underway. We have optimized and determined various steps and thresholds in the process including minimum required cell number, minimum required viability, enrichment protocols, dead cell removal, bead and antibody titrations etc. We have also generated working scripts for streamlined computational analysis of these omic datasets.